Massachusetts AI and Technology Center for Connected Care in Aging and Alzheimer's Disease (MAITC): Administrative Core

PROJECT SUMMARY: Administrative Core
Within the Massachusetts AI and Technology Center for Connected Care in Aging and Alzheimer's Disease
(MAITC), the Administrative Core will direct and support the Center’s varied initiatives, coordinate internal and
external communication, provide budgetary and financial support, and oversee the pilot project programs. The
MAITC Administrative Core will help establish a robust pilot project research program and build an extensive
network of technology researchers, stakeholders and industry representatives working to develop, validate and
deploy innovative technologies to support successful aging and care for patients with Alzheimer’s disease (AD)
and related dementias (ADRD) at home.
To accomplish these goals, this Administrative Core will pursue three specific aims. The first aim is to
strategically direct, and provide scientific oversight, fiscal, and operational support for the MAITC by
establishing committee structures and coordinating interactions between cores. The Administrative Core will
manage committees to carry out the core’s function and manage interactions between the MAITC and the
Coordinating Center, as well as coordinate the outstanding resources available at the numerous MAITC sites
to provide a practical, well-integrated infrastructure to support pilot project teams. The second aim is to
facilitate partnerships between the MAITC and members of the industry consortium as well as external
interactions with a broad array of AI, device technology, clinical and laboratory research programs and
companies interested in supporting successful at-home aging and AD/ADRD Care. We have an outstanding
Industry Advisory Board and Industry Consortium consisting of leaders in corporations, startups and venture
capital (VC) firms and we will maintain and grow these partnerships. We will facilitate multidisciplinary
interactions within the institutions that are part of the MAITC and foster the development of new research
communities by influencing the broader research landscape in this emerging field. The third aim is to oversee a
vibrant, robust and efficient pilot project program that leverages MAITC resources to develop, feasibility-test
and validate existing and emerging AI-enhanced technologies for Healthy Aging and AD/ADRD care. The
Administrative Core will coordinate interactions between cores including needs assessment and technology
identification activities, development and issuing of the call for pilot proposals, multi-disciplinary teaming across
institutions and research areas, and the pilot project selection process. The Administrative Core will also
perform oversight functions and provide post-pilot consultation services. Through these aims, the
Administrative Core will ensure that the activities of the MAITC are conducted in an efficient, effective and
coordinated manner.